Thromboxane Receptor Signaling in Pulmonary Fibrosis

ABSTRACT
Although prostaglandins and their receptors have been studied extensively in pulmonary fibrosis, there is a
paucity of data regarding thromboxane A2 (TXA2) and the thromboxane-prostanoid receptor (TPr) in the lungs.
We found that TPr is expressed in lung fibroblasts and that expression of this receptor is upregulated in
fibroblasts from patients with idiopathic pulmonary fibrosis (IPF), as well as lung fibroblasts from mice treated
with bleomycin. Genetic deletion of TPr in mice or treatment with a TPr antagonist (Ifetroban) markedly
attenuated bleomycin-induced lung fibrosis. In addition, TPr deficiency or Ifetroben treatment reduced
Smad2/3 phosphorylation, α-smooth muscle actin (α-SMA) expression, and collagen 1 production in lung
tissue and isolated lung fibroblasts following bleomycin treatment, without effects on inflammation or epithelial
apoptosis. In contrast, treatment with a thromboxane synthesis inhibitor (Ozagrel) was minimally effective at
inhibiting lung fibrosis. These findings, along with data showing that thromboxane expression was only
transiently upregulated following bleomycin treatment, suggested that TPr activation in fibrosis is mediated
through an alternative ligand. F2-isoprostanes (F2-isoPs) are a non-enzymatic product of reactive oxygen
species (ROS)-induced peroxidation of arachidonic acid that have structural similarities to TXA2 and can
activate TPr signaling. Following treatment with bleomycin, F2-isoPs in mouse lungs were persistently
upregulated, suggesting that these ROS products could mediate lung fibrosis via TPr activation. To further
investigate mechanisms by which TPr regulates fibrosis, we exposed mouse lung fibroblasts to F2-isoPs (or the
specific TPr agonist U-46619) and observed myofibroblast differentiation, increased proliferation, and Smad2/3
phosphorylation, and collagen production, all of which were blocked by deletion of TPr or Ifetroban treatment.
Further, in primary lung fibroblasts from IPF patients, we found that TPr antagonism reduced cell proliferation
and expression of α-smooth muscle actin and collagen 1. Together, these data support the hypothesis that
reactive oxygen species produced in the lungs of IPF patients generate F2-isoprostanes which activate TPr
signaling in lung fibroblasts, leading to myofibroblast differentiation and persistent collagen and matrix
production through downstream activation of the Smad/TGF-β pathway. Interventions that block TPr signaling
could provide novel therapeutic options to limit progressive pulmonary fibrosis. Specific Aims will: 1)
determine the role of TPr signaling in lung fibroblasts in relevant pre-clinical models of lung fibrosis, 2) identify
mechanisms by which TPr signaling regulates myofibroblast differentiation and activation, and 3) examine the
anti-fibrotic effects of TPr inhibition in human lung fibroblasts and 3-D pulmosphere cultures. Since TPr
antagonists, including Ifetroban, are currently available for human use, these studies are likely to set the stage
for future clinical studies targeting this pathway (alone or in combination with current drugs) to improve
outcomes in IPF and related diseases characterized by progressive pulmonary fibrosis.

Public health relevance
NARRATIVE Despite the hard work of many investigators, the underlying mechanisms of progressive fibrosis in idiopathic pulmonary fibrosis (IPF) remain incompletely understood. In this proposal, we have outlined a comprehensive approach to evaluate thromboxane receptor signaling as a novel pathway that contributes to persistent fibroblast activation in the lungs. If successful, these studies could pave the way for rapid translation into clinical studies with the goal of improving outcomes in IPF and related fibrotic diseases.